CHARACTERIZING AGGRESSIVE GLIOMA COPY NUMBER SUBTYPES

PROJECT SUMMARY/ABSTRACT This proposal describes a 5-year career development program in which the applicant’s ultimate goal is to become an independent physician-scientist with a focused clinical practice in neuropathology and a research laboratory dedicated to the study of diffuse gliomas. The proposed research project will capitalize on the expertise and resources available at the University of Washington/Fred Hutchinson Cancer Research Center Cancer Consortium, which has a proven track record of developing physician-scientists. Dr. Eric Holland, an expert in mouse models of glioma and cancer biology, will serve as the applicant’s research mentor. Diffuse gliomas comprise the most common and malignant primary intracranial neoplasms in adults. Furthermore, over the last several decades there has been little success in prolonging the survival of patients with diffuse glioma, and there is yet to be effective targeted therapies. One proposed mechanism for poor treatment response of diffuse glioma lies in the intra- and inter-tumoral molecular and cellular heterogeneity that make up these tumors. Over the last 3 years, the applicant has worked in Dr. Holland’s laboratory to address this molecular heterogeneity within glioma, specifically investigating the role of somatic copy number alterations (SCNAs). Through copy number profiling across adult glioma cohorts, prognostic SCNA subtypes were defined with clear differences in median survival and selection biases were found to exist in smaller cohorts, having implications on clinical trial design and applicability to the general population. Along with these human biomarker projects, studies of pre-clinical glioma mouse models have been underway to begin to elucidate genetic drivers associated with SCNAs in glioma. One such study identified HOXA5 as being a driver of chromosome 7 gain in glioma, with HOXA5 driving an aggressive glioma phenotype including mediating radioresistance in vivo. Combining the applicant’s previously published work with other preliminary data, the underlying biology of SCNA subtypes will be addressed in the current proposal, primarily through the construction of SCNA subtype glioma mouse models, which will be functionally characterized (Aim 1). Additionally, the organismal and cellular consequences of SCNA subtype-specific responses to standard therapy (Aim 2) as well as immunotherapy (Aim 3) will be characterized. Overall, the candidate’s background in human and animal investigative and diagnostic neuropathology is well-suited for this mentored research project focused on characterizing biological consequences of SCNAs in gliomas and may yield novel approaches for the treatment of this malignancy. Importantly, the proposed research also establishes a model system for studying glioma-associated SCNAs and associated driver genes in gliomagenesis, which will provide the applicant with the foundation for an independent research program.

Public health relevance
PROJECT NARRATIVE Somatic copy number alterations (SCNAs) form prognostic molecular subtypes of diffuse glioma with clear differences in mean overall survival. The proposed studies will use an established in vivo mouse model of glioma to understand the biology underlying SCNA subtype biology at the molecular, cellular, and organismal levels. These experiments will provide a pre-clinical roadmap to understanding differential treatment responses across SCNA glioma subtypes and will provide rationale for designing subtype-specific therapeutic strategies.